Chaperone-Mediated Autophagy in Cardiac Fibrosis

ABSTRACT
Repair of the infarcted heart is dependent on timely activation and de-activation of fibroblasts and
myofibroblasts. In the infarcted myocardium, fibroblasts undergo dynamic phenotypic transitions that require
rapid turnover of their intracellular proteins. This constant renewal of the proteome involves not only
transcriptionally-driven activation of protein synthesis, but also selective patterns of protein degradation.
Chaperone-Mediated Autophagy (CMA) can selectively remove specific proteins to terminate their function,
regulating a range of cellular processes, including survival, proliferation and differentiation. Our preliminary data
show that myofibroblast-specific disruption of CMA perturbs repair following myocardial infarction, reducing
recruitment of activated myofibroblasts, and that fibroblast CMA stimulated migration and collagen lattice
contraction. The cardiac reparative defects of myofibroblast-specific CMA loss are similar to the adverse
consequences of aging, which also impairs myofibroblast infiltration and is associated with attenuated CMA
activity. Accordingly, we hypothesize that CMA is dynamically regulated in fibroblasts undergoing
phenotypic transitions in infarcted hearts, and plays a central role in repair, by modulating the proteomic
profile, phenotype and function of reparative fibroblasts and myofibroblasts. The hypothesis will be tested
in 4 specific aims:
Aim 1: to study the role of fibroblast and myofibroblast CMA in repair and remodeling of the infarcted
heart, using mice with cell-specific disruption of lysosomal-associated membrane protein type 2A
(LAMP2A), the critical lysosomal membrane protein involved in binding and internalization of CMA
substrates.
Aim 2: to study the role of CMA in regulating the phenotypic transitions of infarct fibroblasts and to
explore the link between CMA activation and infarct fibroblast heterogeneity.
Aim 3: to study the effects of CMA in regulation of fibroblast responses and to identify specific CMA
substrates that may be implicated.
Aim 4: to examine whether accentuation of CMA in infarct fibroblasts and myofibroblasts improves
repair and attenuates adverse remodeling and to explore the effectiveness of therapy with CMA activators
in healing infarcts in both young and old mice. Effects of genetic overexpression of LAMP2A in infarct
fibroblasts and myofibroblasts will be studied. Moreover, the effects of treatment with first-in-class small
molecule CMA activators in young and old mouse infarcts will be investigated.
The proposed studies will provide the first evidence on the role of CMA in repair and fibrosis of the
infarcted heart and may suggest novel therapies targeting CMA in order to improve cardiac repair.

Public health relevance
NARRATIVE: Repair of the infarcted heart requires timely activation of fibroblasts and myofibroblasts. Our proposal will test the hypothesis that the phenotypic transitions of fibroblasts and myofibroblasts in the infarcted heart require renewal of the proteome, regulated not only through transcriptional mechanisms, but also through selective patterns of protein degradation. Our proposal examines for the first time the role of Chaperone-Mediated Autophagy (CMA), a selective form of protein turnover, in regulation of fibroblast phenotype in the infarcted heart. To test the hypothesis, we will use cell-specific loss- and gain-of-function models in vivo and a wide range of in vitro assays. Moreover, we will examine whether stimulation of CMA in fibroblasts and myofibroblasts can correct aging-associated reparative perturbations after myocardial infarction.